USE OF DIANEAL IN CONTINUOUS AMBULATORY DIALYSIS PATIENTS

LAB USE ONLY. To evaluate nutritional and metabolic effects of the addition of an amino acid solution to dialysis fluid in chronic ambulatory peritoneal dialysis (CAPD) patients.